Defining Structural and Functional Differences Between Cytochrome P450 11B1 and 11B2 Interactions with Redox Partner Adrenodoxin for Developing Cushing's Disease and Primary Aldosteronism Treatments

PROPOSAL SUMMARY
Human membrane cytochrome P450 (CYP) enzymes 11B1 and 11B2 catalyze the final steps in cortisol
and aldosterone synthesis, respectively. Excess cortisol causes Cushing’s disease, leading to weight gain and
immune suppression (2), whereas excess aldosterone causes primary aldosteronism, leading to hypertension
(3). Treatment options for both disease states have been limited by poor drug selectivity, resulting from the high
sequence homology between CYP11B1 and CYP11B2, especially in their active sites. This proposal aims to
identify structural and functional differences between these enzymes that could be used to inform development
of selective drugs for Cushing’s disease and primary aldosteronism. One difference between the CYP11B
enzymes lies in their interaction with their shared redox partner, adrenodoxin. My preliminary data with CYP11B1
and previous Scott lab studies on CYP11B2 demonstrate that adrenodoxin allosterically modulates both CYP11B
enzymes, but with different impacts on each enzyme (9). This suggests potential differences in how adrenodoxin
binds the two CYP11B enzymes--differences that could be targeted to develop drugs that selectively block only
one enzyme. However, the basis for adrenodoxin’s allosteric effect has not been well-characterized. This
proposal seeks to fill this gap by structurally and functionally characterizing the adrenodoxin allosteric effect on
each CYP11B enzyme. First, an X-ray structure will define the residues forming the CYP11B1/adrenodoxin
interface for comparison with an existing structure of the CYP11B2/adrenodoxin complex. Second, pre steady--
state kinetics using stopped flow will determine whether adrenodoxin binding on the P450 surface changes the
P450 interactions with ligands in the distant buried active site by primarily altering ligand binding or release.
Finally, mutagenesis studies will investigate the effect of a specific loop hypothesized to be responsible for the
differences in the allosteric effect among human P450 enzymes. Overall, this study will provide a broad structural
and functional characterization of the adrenodoxin allosteric effect on CYP11B1 and CYP11B2. This detailed
characterization advances our understanding of the biochemical system but also has the potential to reveal
differences between the two enzymes useful in developing selective drug treatments for both Cushing’s disease
and primary aldosteronism.

Public health relevance
PROJECT NARRATIVE Cytochrome P450 (CYP) 11B1 and 11B2 synthesize cortisol and aldosterone respectively, with excesses resulting in Cushing’s disease and primary aldosteronism. Drug treatments for each disease are limited due to poor drug selectivity resulting from the high similarity between these enzymes. This proposal aims to define differences between CYP11B1 and CYP11B2 active sites and interactions with common redox partner adrenodoxin, advances that may facilitate more effective drug design.